ExRNAs for early identification of pregnancies at risk for placental dysfunction

DESCRIPTION (provided by applicant): Placental dysfunction, most commonly manifested as preeclampsia or intrauterine growth restriction, is an important cause of maternal and fetal morbidity and mortality in both the developing and developed world. It is thought that placental dysfunction arises from abnormal trophoblast differentiation and/or invasion, events that occur in the first trimester of pregnancy, but become clinically apparent only in the late second and third trimesters. Optimal surveillance and management of placental dysfunction, as well as the development of effective therapies, have been hampered by the lack of methods for early and accurate identification of pregnancies at risk for this disorder. This project aims to develop such a method. The goal of Aim 1 will be to identify candidate Extracellular RNA biomarkers for prediction of clinically relevant placental dysfunction from a high-risk cohort. Aim 2 will focus on validation of these biomarkers in an average-risk cohort. Aim 3 will include development of a CLIA certified assay and application of this assay in a pilot randomized control trial to assess the clinical and cost impact of screening general obstetric population for risk of placental dysfunction, and referral of screen-positive patients to a higher level of surveillance. This project is a collaboration between academia (UCSD) and industry (Sera Prognostics) and will leverage existing and in-progress resources, including the Placental Dysfunction Clinic at UCSD, the plasma and serum biobank collected from average-risk pregnancies at Sera Prognostics, and the UCSD Obstetric Registry. The research team includes investigators with diverse and complementary strengths, including expertise in maternal fetal medicine, clinical research, epidemiology, genomics, bioinformatics, molecular biology, and clinical assay development. The immediate application of a simple and accurate method to predict risk of clinically relevant placental dysfunction to obstetric care will be to enable targeting of clinical resources to high-risk cases, while sparing low risk patients unnecessary anxiety. Longer term benefits will arise from using this method to increase the safety and power of clinical trials of candidate therapies by targeting high-risk patients, thus enhancing the detection of any therapeutic effects and subjecting only the patients most likely to benefit to potential risks associated with the therapy.

Public health relevance
PUBLIC HEALTH RELEVANCE: The primary goal of this project is to identify extracellular RNA biomarkers for accurate assessment early in pregnancy of a patient's risk of developing preeclampsia or intrauterine growth restriction (IUGR). This information is relevant to public health because preeclampsia and IUGR are major causes of maternal and fetal morbidity and mortality, and current methods for prediction of these complications of pregnancy have poor sensitivity and specificity. Accurate risk assessment will enable high-risk patients to be monitored appropriately so that preeclampsia and IUGR can be diagnosed promptly, while sparing low-risk patients unnecessary anxiety. __SpecificAimsTextDelimiter__ Specific Aims Specific Aim 1 (UH2, Years 1-2). Discovery phase. 1.1. Recruit study subjects at high risk for preeclampsia/IUGR (Year 1, Year 2 months 1-6). Laurent. Study subjects will be recruited at 22-26 weeks gestation from the high-risk patient population in the UCSD Placental Dysfunction Clinic, which has a 35% incidence of preeclampsia or IUGR over the course of pregnancy. 1.2. Collect/process specimens from enrolled subjects (Year 1, Year 2 months 1-6). Laurent. Plasma and serum samples will be collected, aliquoted, and cryopreserved serially through pregnancy from each enrolled subject. 1.3. Collect demographic and clinical data (antepartum, intrapartum, postpartum/neonatal, placental histology) (Years 1-2). LaCoursiere/Laurent. Comprehensive demographic and clinical data will be collected on each enrolled subject and entered into the UCSD Obstetric Registry. These data will be used to select a case-control cohort (27 cases and 27 controls) from the enrolled subjects. 1.4. RNAseq and small RNAseq on Extracellular RNA from specimens (Year 2). Laurent. Strand-specific RNAseq and small RNAseq will be performed on specimens collected at the time of enrollment (22-26 weeks gestation) from the selected cases and controls. 1.5. Bioinformatic analysis comparing cases and controls to identify Extracellular RNAs (mRNAs, small RNAs, lncRNAs) that are enriched or depleted in cases compared to controls (Year 2 months 10-12). Laurent. Supervised statistical methods will be applied to identify Extracellular RNAs that are differentially present in the specimens from the cases compared to the controls. 1.6. Bioinformatic analysis using detailed clinical data to identify subcategories of disease (Year 2 months 10- 12). Laurent. Unsupervised and semi-supervised data analysis methods will be used to discover and classify subcategories of placental dysfunction, and identify biomarkers specific to each of these subcategories. 1.7 Assessment of behavior of candidate ExRNA biomarkers longitudinally in affected and unaffected pregnancies. Laurent. The levels of the candidate ExRNA biomarkers from Aim 1.5 and Aim 1.6 will be measured in the specimens collected longitudinally through pregnancy in the cases and controls to determine their value in predicting the timing of onset of clinically apparent placental dysfunction. Specific Aim 2 (UH3, Year 3): Validation phase. The performance of the candidate biomarkers identified in Aim 1 from a high-risk cohort will be validated in an independent average-risk cohort, with biospecimens provided by Sera Prognostics from an existing biobank. 2.1. Validation of candidate biomarkers on a cohort of average-risk patients (Year 3). Sera/Laurent/LaCoursiere. 2.2. Validation of subctegory-specific candidate ExRNA biomarkers. Sera/Laurent/LaCoursiere. Specific Aim 3 (UH3, Years 3-5): Interventional phase. Clinical testing of ExRNA biomarker assay. 3.1. Design and CLIA certification of clinical biomarker assay. Laurent and selected service provider. Since the results of the biomarker assay will be used to make recommendations pertaining to clinical care, the assay must be CLIA certified and performed in a CLIA certified environment. 3.2. Development of clinical trial database (Year 3). LaCoursiere. A customized database for this study will be developed as part of the UCSD Obstetric Registry. 3.3. Submission/approval of clinical trial protocol. (Year 3). Laurent. 3.4. Interventional trial (Years 4-5). Laurent/LaCoursiere. 500 control and 500 test cases will be enrolled to determine whether recommendations on clinical surveillance based on results of the clinical biomarker assay has an impact on clinical and/or cost effectiveness outcomes.